Evaluating Impact of Mobile Community Education Engagement Initiative on Perceptions and Behaviors Related to Clinical Research Among Underserved Populations

Underserved communities are underrepresented in clinical research. The resulting lack of
clinical data on these populations perpetuates health inequities. Engaging diverse communities
in clinical research is a priority for academia and industry alike, and both have devoted
significant resources to developing educational materials and recruiting diverse populations for
clinical research. However, those efforts have not resulted in clinical research participation that
reflects the diversity of patient communities. Sometimes, community members feel tokenized
instead of valued as partners in the research process. Other times, the outreach efforts never
reach the intended audiences or do not arrive through trusted channels. Our proposed project
will address these challenges by leveraging grassroots community engagement to bring clinical
research education into the heart of two diverse cities. The proposed pilot program devotes
several months to cultivating community engagement and establishing community ownership of
the program in each city. It does so through collaboration with community leaders, community
educators, local media, and patient and public advocacy groups. Working together, CISCRP
and engaged community partners will bring a mobile educational exhibit about clinical research
to each city for two weeks. The exhibit will be staffed by local community educators and located
at strategically selected cultural, sporting and health-related events within diverse, underserved
areas. CISCRP will solicit feedback from community partners to identify improvements and
develop best practices for grassroots community engagement. We will conduct surveys among
exhibit guests at three key time points to understand how mobile, community-based education
affects their attitudes and experiences with clinical research. This pilot program is an innovative
initiative to support a range of community partners in bringing clinical research education to their
communities. This research will provide critical insights into the impact of this grassroots
program model on underserved communities’ perceptions of, and engagement with, clinical
research.

Public health relevance
Engaging members of underserved communities in the clinical research process is imperative for health equity. The proposed pilot project devotes several months to cultivating community engagement and establishes community ownership of a program that brings a mobile educational exhibit about clinical research into underserved communities. If we find that the approach improves attitudes and affects behaviors related to clinical research among program participants, it will serve as a powerful model for advancing diversity in clinical research.